CRCNS: Dissection and control of cognitive thalamocortical dynamics

PROJECT SUMMARY (See instructions):
Cognitive flexibility, the ability to mentally switch between different thoughts and action plans, is critical for
survival in a rapidly changing environment. Impaired cognitive switching capacity is characteristic of the
cognitive inflexibility seen in multiple mental illnesses such as schizophrenia. Despite the fundamental
importance and

Public health relevance
public health relevance, the circuit and computational principles underlying cognitive flexibility are poorly understood. The prefrontal cortex (PFC) and mediodorsal (MD) thalamus play a critical role in cognitive flexibility, disrupted PFC or MD activity or their temporal coordination may lead to impaired flexibility in attentional control, working memory and decision making. Guided by the converging evidence from the literature and our own preliminary data, we propose that temporal coordination between the MD and PFC in the beta/gamma range enable optimal cognitive control, and that their perturbation underlies some of the cognitive deficits in schizophrenia. We will develop experimental and computational tools that further clarify this link along with a set of interventional tools that may ultimately be deployed in human patients. Our central hypothesis is that temporal coordination of the MD and PFC neural activity (spikes and local field potentials) provides a readout of animal's "state-of-mind" during working memory, and that temporally patterned MD neurostimulation provides an effective strategy to enhance prefrontal engagement in cognitive processing. Specifically, we will combine multidisciplinary techniques (genetic mouse model, animal behaviors, multisite electrophysiology, optogenetics, closed-loop brain-machine interface, machine learning and computational psychiatry) to understand temporal dynamics of coordinated MD-PFC neural activity during flexible cognition tasks for both schizophrenic and wild-type mouse models. In Aim 1, we will test the hypothesis that MD-PFC oscillatory entrainment deficits co-vary with task-switching impairments in a high-penetrance genetic model relevant to schizophrenia. In Aim 2, we will develop closed-loop patterned stimulation strategies to modulate MD-PFC circuits for improving cognition. In Aim 3, we will develop spiking recurrent neural network models as a general platform for prototyping interventions in the MD-PFC loop for cognitive dysfunction. Accomplishment of these aims is highly significant for gaining translational insight into a wide range of neuropsychiatric disorders related to cognitive dysfunction.